Sickle Cell Disease Stem Cell Repository

We plan to recruit volunteers with SCD as healthy donors for collection of peripheral blood stem cells by apheresis. Volunteers will be treated with plerixafor, a drug that we and others have shown to mobilize peripheral blood (PB) CD34+ cells safely in SCD patients. The collected stem cells will be purified by magnetic separation using CD34 beads, validated, frozen, and then provided as a resource to investigators working on developing therapies for SCD.